Death One Hour After Terminal Extubation (DONATE) 2.0 Study

PROJECT SUMMARY/ABSTRACT
Children have the highest mortality rate on the organ transplant waiting list compared to any other age
group, including elderly adults. Organ donation after circulatory death (DCD) has increased the number of
available organs, but the process is challenging. In DCD, organ procurement necessitates death within a short
period of time after terminal extubation, typically one hour, to avoid ischemic damage to the donor organ. If a
child does not die within the organ recovery period, they are considered ineligible to donate. While DCD has
the potential to save the lives of children who would otherwise die due to lack of transplantable organs,
unsuccessful DCD attempts are highly resource intensive and can place additional emotional strain on a
grieving family. To balance these competing issues, there is a critical need to accurately predict which patients
will die within the organ recovery period. Our team trained and tested the high-performing Death One Hour
After Terminal Extubation (DONATE) machine learning model using multi-site data to predict whether a patient
would die within one hour after terminal extubation. Using this model, we designed a prototype of a clinical
decision support (CDS) tool to aid clinicians in their assessment of DCD candidacy, which we aim to test and
eventually use in clinical practice. Unfortunately, even successful models and CDS tools often fail translation
into practice because this is attempted without sufficient attention to real-world use, clinician input, and clinical
context. Implementation science frameworks must be used to rigorously study the users and environment prior
to deployment of any new model or tool.
The proposed research has two specific aims: (1) to validate the DONATE model’s performance at
different time points prior to terminal extubation so that the recommended time range for clinical use of the
model can be defined, and (2) to define the facilitators of and barriers to implementation of the DONATE model
in the pediatric intensive care unit (PICU) and to test the usability of the CDS tool prototype. To accomplish
Aim 1, we will perform a retrospective cohort study of patients terminally extubated in 5 PICUs from 2022-
2023. We will assess the model’s performance when it is used at different time points prior to terminal
extubation. Metrics will include area under the receiver operator characteristic curve, sensitivity, false positive
rate, positive predictive value, and number needed to alert. For Aim 2, we will perform semi-structured
interviews with PICU clinicians at two sites and test the usability of the CDS tool prototype with simulated
patient data. We will perform coded analysis to establish themes based on the Consolidated Framework for
Implementation Research. Participants will answer validated survey questions on the user experience. We will
make user-informed adaptations to the CDS tool prototype. After completion of these aims, we will have
generated a user-informed CDS tool prototype that is ready for development and EHR integration, as well as
candidate implementation strategies to support a Type 1 multi-site hybrid effectiveness-implementation trial.
Click here to enter text.

Public health relevance
PROJECT NARRATIVE Many children die on an organ transplant waiting list because there are not enough pediatric organs available for transplant. The supply of organs can be increased by attempting more organ donation after circulatory death, but this requires accurate understanding of which patients are likely to die within the organ recovery period. Our team has developed a machine learning model to predict this outcome, and in this proposal, we aim to lay the foundation for the model's implementation by validating it at different time points to inform appropriate clinical use and studying the users and clinical environment to facilitate uptake.